Cell and Tissue Shared Resources

The goal of the Biostatistics and Bioinformatics Shared Resource (BBSR) is to provide basic, translational, clinical and population science investigators at the Lombardi Comprehensive Cancer Center (LCCC) with access to high quality statistical science and informatics. Ming Tan, PhD, Chair of the Biostatistics, Bioinformatics, and Biomathematics Department and Subha Madhavan, PhD, Director of Innovation Center for Biomedical Informatics are Codirectors of BBSR. BBSR functions include: study design; statistical analysis and reporting of research studies including clinical trials, studies with high dimensional

Public health relevance
The Biostatistics and Bioinformatics Shared Resource (BBSR) provides the critically needed study design, power analysis, data management, bioinformatics and data interpretation support for all LCCC Research Programs.